CELLULAR DELIVERY MECHANISMS OF OLIGONUCLEOTIDES MEDIATED BY CATIONIC LIPIDS

Our objectives are to study the intracellular trafficking of oligonucleotides delivered by cationic lipids and the parameters influencing the delivery, to determine the uptake pathway followed by the nucleic acid/cationic lipid complexes, and to demonstrate the mechanism of oligonucleotide release from cationic lipids in cells. The understanding of such cellular delivery mechanims will allow us to develop a more rational approach to develop new nucleic acid carrier systems. We are using the facilities available through the Computer Graphics Laboratory to analyse nucleic acid sequences.